Enhancing Measurement and Characterization of Roles and Experiences of Sexual Minority Caregivers of Persons living with Alzheimer's Disease and Related Dementias

Sexual minorities (SM), defined here as individuals whose sexual orientation differs from the heterosexual majority, continue to be underrepresented in Alzheimer’s disease and related dementia (ADRD) caregiving research. Estimates suggest at least 1 in 5 SM adults in the U.S. (nearly 1 million persons) are currently caregivers, with nearly half providing care to someone with ADRD. Our previous research has found that SM caregivers experience health disparities, including greater challenges to optimal health, depression, disability, and stress (e.g., physical, emotional, and financial strain). Given the critical contributions of informal caregivers to ADRD care and the changing nature of caregiver dynamics, roles, and needs, it is crucial that measures relating to caregiving accurately reflect all caregivers. This study proposes to enhance understanding of experiences, roles and dynamics for SM ADRD caregivers by identifying existing domains and developing new measures, testing and validating these measures, and ensuring measures accurately capture caregiving constructs and experiences of SM ADRD caregivers. Guided by a community based participatory approach, we will leverage expertise of advisory boards with knowledge of SM ADRD and caregiving research. This mixed method study has three specific aims. In Aim 1, we will identify and explore domains of ADRD caregiving for SM ADRD caregivers through focus groups (n=8) and in-depth interviews (n=40). These findings will inform Aim 2 and the identification of key domains and subdomains. In Aim 2, we will develop and refine new measures of ADRD caregiving for SM ADRD caregivers through the use of a modified online Delphi method that will garner input from advisory boards (community partners/researchers, n=40) with expertise in ADRD caregiving measures and the lived experiences of SM and non-SM ADRD caregivers. To ensure content validity of the new ADRD measures, they will be pretested and refined based on initial testing (n=40) and cognitive interviews (n=20) with SM and non-SM caregivers. In Aim 3, we will then test the new and existing measures of ADRD caregiving among a sample of SM (n=250) and non-SM ADRD caregivers (n=250). After evaluating the dimensionality structure of each item pool for a given domain and removing misfitting items, we will use item response theory (IRT) and an IRT-based model fit to further evaluate for item misfit. Finally, the resulting measures will be evaluated within an independent sample of SM (n=125) and non-SM (n=125) caregivers. This study’s iterative process will allow for the development of 6 to 8 new or modified caregiving measures that can help to improve access to supports and services of SM ADRD caregivers, and ensure that future studies and intervention efforts can meet the needs of all ADRD caregivers and their care recipients.

Public health relevance
This study is designed to enhance understanding of the measurement of experiences, roles and dynamics for sexual minority (SM) caregivers of persons living with Alzheimer’s disease and related dementias (ADRD). The study will identify existing domains and develop new measures of ADRD caregiving, test and validate these measures, and ensure measures accurately capture caregiving constructs and experiences of SM ADRD caregivers. Our long-term goals are to ensure that SM ADRD caregivers are included in ongoing ADRD caregiving research and measures, and that future interventions can support all ADRD caregivers and their care recipients.